Collaborative Biostatistical Research

The PI collaborated on several projects with researchers in the DiPHR and DIR as follows:
1. NICHD Fetal Growth Studies (PI: Dr. Katherine Grantz): The PI of this report collaborated on several projects led by Dr. Grantz listed below. It is well-known that physical activities during pregnancy are associated with several perinatal benefits. However, the patterns and types of activities, such as office work, household work, commuting and others are not well characterized in the literature. In Mitro et al. (2022), the authors investigated longitudinal activities of pregnant mothers by domain of activity and maternal characteristics. Growth of fibroids in the general population of premenopausal women is very well described in the literature. However, this is not the case during pregnancy. Using longitudinal ultrasound images taken during pregnancy, volumetric changes in fibroids over the course of pregnancy was studied. It is well-known that uterine fibroids are hormonally mediated. There are many environmental toxins that are known to be endocrine disrupters. In a third project, the associations of endocrine disrupters per- and polyfluoroalkyl substances (PFAS) and fibroid changes in pregnancy was investigated.

2. Upstate KIDS follow-up study (PI. Edwina Yeong): Dr. Yeung and her colleagues are interested in understanding physical activities patterns of kids as a function of type of care they receive during the day, adjusting for various socio-economic factors and other covariates. Since the physical activity data are compositional, in Putnick et al. (2022, in preparation) a novel compositional methodology is developed.

3. Vaginal microbiota and pregnancy (PI. Dr. Roberto Romero): The PI of this report is collaborating on several projects with Dr. Romero on the role of vaginal microbiome on pregnancy outcomes. These projects are various stages of completion.

4. To understand the differences in the gut microbial compositions among pregnant women who had asthma compared to those with well-controlled or poorly controlled asthma condition, the PI is obtaining microbiome data using the biospecimen collected in the NICHD's B-WELL-Mom study.